DGRC Resource Core

Project Summary:
The Drosophila Genomics Resource Center (DGRC) supports the international community of
scientists utilizing Drosophila melanogaster for biomedical research. The mission of the
DGRC is to 1) provide broad access to genomics resources by acquiring, archiving, curating,
and distributing genomics resources including clones, vectors, and cell lines; 2) facilitate
effective use of these genomics resources by providing guidance and support; and 3)
improve the genomics resources and protocols available for Drosophila research. By
preserving vital research materials and distributing them efficiently, the DGRC assures
economical access and enhances scientific rigor and reproducibility. The first aim of this
proposal is to continue and strengthen the successful DGRC programs for acquiring,
distributing genomics resources and facilitating their effective use. This will include
augmenting and updating data management systems, the web interface and user support, as
well as continuing the effective cost recovery program. The goal is to maximize the long-term
viability of the DGRC and its benefits to users and the NIH. The second aim is to increase the
utility of Drosophila as a model system by generating new resources through four projects: 1)
surveying the transfection and CRISPR/Cas9 efficiency of gene tagging across
modENCODE cell lines, 2) generating a universal CRISPR/Cas9 based transfection toolkit
for the insertion of constructs and the subsequent ability to generate stable transformants in
any Drosophila cell line, 3) establishing a neuroblast cell line as a model for stem cell
biology, and 4) creating new metabolic sensors for characterizing physiological processes in
cell lines and Drosophila tissues.

Public health relevance
Project Narrative: The proposed research is relevant to public health and the mission of the NIH because Drosophila has been and continues to be a leading model organism to study fundamental biological processes and molecular and cellular mechanisms of human disease. The Drosophila Genomics Resource Center is a central repository and distribution center for genomic resources essential for research in Drosophila.